Variance as a Predictor of Health Outcomes (Resub)

Abstract The purpose of the proposed research is to develop a suite of flexible statistical models and computationally scalable inferential methods to understand how variability of biomarkers may be associated with future health outcomes. While variance is typically understood as nuisance — the “noise” in “signal-to-noise” — there is increasing evidence that underlying variability in subject-level measures over time may also be important in predicting future health outcomes of interest. Previous work in this area has focused on using repeated measures on predictors, one-at-a-time, to develop subject-level mean and variance estimates to use as predictors in joint models of binary outcomes. The technological advances in scientific measurements have resulted in biomarkers that are multivariate, mixed-scale, and obtained at increasingly higher time resolutions. While the scope of scientific questions involving the use of biomarkers in clinical studies has greatly expanded, statistical method development has not kept apace. The proposed research will extend existing work to model time-to-event outcomes, to perform multi- outcome modeling of both scalar and multivariate outcomes as functions of multiple sets of longitudinal predictors, and to deal with high dimensional longitudinal predictors such as those provided by repeated long-term surveillance in prospective cohort studies and by biometric ecological momentary assessment (EMA) measures.

Public health relevance
Longitudinal data has become a major part of the landscape for clinical and epidemiological research. While a great deal of statistical methods development has been focused on the use of mean trends obtained from longitudinal data, approaches that incorporate subject-level variability are far rarer, and consequently use of such information is rare. We propose methods to incorporate variability of predictors in a wide range of statistical modeling settings. We focus on their application in women's health and ecological momentary assessment, but believe their use could be far broader as we move into a world of social media web scraping, administrative data, and other novel data sources. These methods are highly novel with a major potential payoff in the world of “big data.”